Virtual neuro-navigation system for personalized,community-based TMS

ABSTRACT
Transcranial magnetic stimulation (TMS) is an FDA-approved treatment for treatment-resistant
major depression (TRD). However, at present the approach is only partially effective, due in part
to relatively ineffective targeting approaches. Over recent years, there has been increasing
realization that TMS for anhedonic-like symptoms of major depressive disorder (MDD) is most
effective when targeted at the region of left dorsolateral prefrontal cortex (L-DLPFC) that is
maximally anti-correlated with subgenual anterior cingulate cortex (sgACC) as determined using
resting-state functional connectivity MRI (rsfcfMRI). Ideal approaches for identifying this location
for individual subjects, however, still depend on processing pipelines that are not FDA cleared
and thus and are not accessible to the TMS treatment community. In general, 3D brain
reconstructions can be analyzed using either traditional, volumetric approaches, or more recently
developed surface-based approaches developed as part of the human connectome project (HCP)
and leading to publication of the HCP multimodal brain atlas (HCP MMP1.0). In volumetric
approaches, structurally and functionally based approaches have both been implemented. In the
surface-based HCP MMP1.0 approach, structural and functional data are merged to identify
functionally discrete brain parcels across individuals. Here, during phase I we will first develop an
investigational software package (“TMS-Targets”) that will permit TMS researchers to utilize either
volumetric or surface-based analytic approaches for determining MR-based personalized L-
DLPFC target locations on-line, and will create a parallel off-line virtual neuro-navigation tool to
permit neuro-navigated TMS even for “community” practioners without access to on-line neuro-
navigation capabilities. During phase II we will create a Picture Archiving and Communication
System (PACS) compliant clinic-ready version, which we evaluate in a multicenter randomized
controlled trial in TMS-resistant TRD individuals. We will ensure that all device (software
developed to medical standards) and data (clinical validation) requirements are complete by
Phase II end, to enable pursuing either a 510(k) or de-novo submission with positive clinical
outcome. The project builds both from the long-standing interest of Soterix Medical Inc.(SMI) in
1) the use of combined TMS and neuro-navigation, and 2) the development of automated
targeting software for non-invasive brain stimulation; and from recent research by the principal
investigator at Columbia University (CU) demonstrating 1) anti-correlation of HCP MMP1.0 parcel
46 with sgACC across individuals within the HCP sample and 2) 100% response rate among
TMS-resistant TRD patients (n=10) treated with TMS targeted to HCP MMP1.0 parcel 46.
Moreover, both effective electroconvulsive therapy and effective TMS were associated with rsfc
changes involving DLPFC parcel 46 and additional brain regions. This will be the first software to
permit FDA-cleared functional targeting of TMS coil placement using functional as well as
structural information, the first to permit virtual as well as on-line neuro-navigation and the first
study to evaluate efficacy of surface-based parcel-guided TMS vs. standard of care. If successful,
this project will permit improved, targeting of TMS target location across individuals, as well as
implementation of personalized, MR-targeted TMS even within community treatment settings.

Public health relevance
NARRATIVE Transcranial magnetic stimulation for the treatment of treatment resistant depression is partially effective (~40% response and ~35% remission), in part, due to ineffective targeting strategies. The standard “5-cm rule” approach dominates clinical practice but is known to miss the LDLPFC- the intended target. While on-line neuronavigation approaches that allow incorporating the patient’s LDLPFC from individual MRI are being considered, adoption is slow. Furthermore, DLPFC is divided into 13 distinct parcels and regions. In a pilot study (n=10) of TMS-resistant TRD individuals, by targeting parcel 46 of LDLPFC, we were able to obtain 100% response and 50% remission. We aim to develop a software that will enable not only TMS groups that do not currently have navigation equipment but also groups that do have access to one. The software (“TMS-Targets”) will provide scalp and brain coordinates corresponding to popular volumetric targeting approaches and our surface-based approach. The approaches will be clinically validated and all FDA device and regulatory requirements addressed. We aim to obtain either a 510(k) clearance or a de-novo approval immediately post Phase-2 pending favorable clinical outcome.